Trem2-mediated microglia-neuronal axis in Alzheimer disease pathogenesis

Abstract Alzheimer’s Disease (AD) is the most common cause of ageing-dependent
dementia in the world and is associated with cerebral amyloid plaques, mostly composed of Aβ
peptides, and intraneuronal neurofibrillary tangles, mostly composed by hyperphosphorylated
tau. The impacts of AD on patients, families, caregivers and society are shattering. Regrettably,
AD-modifying drugs are unavailable underscoring the scant understanding of AD pathogenesis.
~5% of AD cases have early onset (<65 yo) and are due to Familial autosomal dominant
mutations in APP, PSEN1 and PSEN2 (FAD); ~95% of cases are sporadic with late onset (>65
yo, SAD). Yet, commonly used animal organisms model FAD. This may be an issue if FAD and
SAD present significant pathogenic differences. If so, therapeutics effective in FAD animals may
have limited efficacy in SAD patients. Thus, models that reproduce the pathogenesis of SAD are
needed to identify therapeutic targets and test SAD-modifying therapeutics. Variants of the
microglia gene TREM2 increase the risk of SAD by 3 fold. To gain insights into the pathogenic
mechanisms of SAD, we generated rats carrying the p.R47H pathogenic variant in the rat
Trem2 gene (Trem2R47H). Rat and human APP differ by 3 amino acids in the Aβ region. These
differences may be crucial in this model organism because: 1) human Aβ possesses higher
propensity to form toxic species as compared to rodent Aβ; 2) the pathogenic role of the p.R47H
TREM2 variant may be linked to deficits in microglia-mediated human Aβ clearance. To
overcome this issue, we humanized the rat Aβ sequence (Apph allele); thus, our rat models
produce human Aβ from the endogenous rat App gene. We choose a knock in (KI) approach
rather than the more common transgenic overexpression approach because KI models make no
preconceived assumption about pathogenic mechanisms, except the unbiased genetic one. In
contrast, transgenic models, which produce high levels of Ab and can readily deposit amyloid
plaques, are based on the hypothesis that plaques and/or other forms of toxic Ab have a central
pathogenic role. We propose to dissect pathogenic mechanisms triggered by the p.R47H
pathogenic variant using these KI rat models. We will also study the impact of Trem2R47H on the
pathological processes triggered by the Apps and Psen1LF FAD mutations. We will analyze
microglia function, cell-to-cell transcriptomic changes in the brain, APP processing, brain
pathology, neuro-inflammation and neurodegeneration, synaptic transmission/plasticity, learning
& memory. Dissecting pathogenic pathways set off by the Trem2R47H variant may pave the way
to therapeutic approaches that can prevent/delay sporadic AD.

Public health relevance
The impacts of Alzheimer disease on patients, families, caregivers and society are shattering. Regrettably, there are no drugs that can cure Alzheimer disease. We have created new rat models of Alzheimer disease: this model will be to identify therapeutic targets and test drugs that will prevent and/or cure Alzheimer disease.